Machine learning-based biomechanical analysis for thoracic aortic aneurysm rupture risk assessment

PROJECT SUMMARY
Aortic aneurysm disease ranks consistently in the top 20 causes of death in the U.S.
population. Thoracic aortic aneurysm (TAA) is a leading cause of death in adults. The progression
of TAA is a silent process, yet rupture/dissection can occur suddenly, which often causes death.
The deadly events are preventable by elective surgical repair, and the current criterion for surgical
intervention states that surgery should be performed when TAA maximum diameter reaches 5 to
5.5 cm. However, this criterion cannot assess the risk of smaller TAAs (diameter≤5cm). It is
estimated that there are millions of TAA patients in the U.S. with smaller TAAs, and these patients
are unfortunately ignored by the current criterion. Thus, in this project, we propose an innovative
approach of integrating machine learning (ML) and computational biomechanics for risk
assessment of smaller TAAs. To achieve this goal, we will develop (1) ML models for automated
thoracic aorta geometry reconstruction from 3D clinical CT images, which will enable a fast and
streamlined analysis of TAA risk, (2) ML models for realtime TAA stress analysis, and (3) a
probabilistic risk index that fuses the measured and computed patient characteristics (e.g.
geometry, stress, material strength, etc) and takes into account uncertainties from different
sources. The proposed approach will be developed and validated on an existing dataset of 1000
patients and a new dataset to be assembled from a longitudinal follow-up study of 600 patients,
which will be the first large-scale study of machine learning-based biomechanical analysis for TAA
risk assessment. This study will lead to a breakthrough in the fields of cardiovascular
computational modeling and applied machine learning, provide new insights on how to better
assess TAA risk, and reduce death by the silent and sudden killer of TAA disease.

Public health relevance
PROJECT NARRATIVE We propose to develop a machine learning-based biomechanical analysis approach for rupture risk assessment of thoracic aortic aneurysm (TAA). This study will lead to a breakthrough in the fields of cardiovascular computational modeling and applied machine learning, provide new insights on how to better assess TAA risk, and reduce death by the silent and sudden killer of TAA disease.